Monitoring and control of human liver cancer ablation using real-time, 3D echo decorrelation imaging

Project Summary/Abstract
Liver cancer, including hepatocellular carcinoma (HCC) as well as metastatic tumors, is a major public health
problem. For patients with unresectable liver cancer, thermal ablation, including radiofrequency ablation (RFA)
and microwave ablation (MWA), is the current clinical standard of care; however, thermal ablation methods are
limited by non-uniform and inconsistent treatment, leading to adverse side effects, local cancer recurrence, and
decreased survival, severely limiting their clinical utility.
Echo decorrelation imaging is a novel ultrasound approach that mitigates these problems by mapping
ultrasound echo changes caused by tissue heating during thermal ablation. Research to date on echo
decorrelation imaging has shown that this method reliably predicts ablation-induced cell death in vivo for rabbit
and porcine liver tissue as well as VX2 liver cancer. Although echo decorrelation imaging is an extremely
promising approach to thermal ablation monitoring and control, its translation to clinical practice will require
validation of real-time, 3D ablation monitoring and control for human liver cancer ablation, including different
tumor types (HCC and metastatic), as well as normal and abnormal human liver parenchyma (e.g., cirrhotic
liver). Our central hypothesis for this study is that real-time monitoring and control by 3D echo decorrelation
imaging will improve reliability of human liver tumor ablation.
To test this hypothesis, we will implement 3D, real-time echo decorrelation imaging using a clinical
ultrasound scanner and matrix array transducers, then validate the application of 3D echo decorrelation
imaging to RFA and MWA. Methods for controlled ablation will be implemented for RFA using standard clinical
electrodes and a clinical radiofrequency generator, with echo decorrelation serving as a treatment end point.
To test the performance of clinical echo decorrelation imaging in human primary and metastatic cancer as well
as diseased liver tissue, 3D echo decorrelation images will be formed from echo data recorded during open
surgical RFA and percutaneous MWA procedures, then compared with follow-up contrast MRI and CT to
assess prediction of ablated volume margins as well as local recurrence. Control of thermal ablation by 3D
echo decorrelation imaging will first be studied in resected specimens of human metastatic liver cancer with
normal liver tissue margins and specimens of cirrhotic human liver tissue, as well as in vivo swine liver. The
study will then culminate in a treat-and-resect trial of echo decorrelation-controlled radiofrequency ablation in
liver tumor patients, demonstrating the direct application of echo decorrelation imaging to improving clinical
tumor ablation. This research will thus show feasibility for both effective prediction and real-time control of liver
cancer ablation in human liver cancer and concomitant diseased liver tissue.

Public health relevance
Relevance Liver cancer is a major public health problem, accounting for the largest cancer-related mortality in the world, with only a small fraction of patients eligible for curative resection or transplantation. Minimally invasive thermal ablation methods are the best available treatment for patients with unresectable liver cancer, but have significant problems with incomplete treatment, tumor recurrence, and complications caused by collateral tissue damage. Real-time three-dimensional ablation monitoring and control by echo decorrelation imaging will significantly improve the safety and efficacy of minimally invasive thermal ablation procedures, ultimately resulting in fewer complications, reduced tumor recurrence, and improved outcomes for cancer patients, and potentially allowing minimally invasive thermal ablation to replace surgical resection as the gold standard for liver cancer treatment.